QT prolonging medications and sudden cardiac death among individuals on hemodialysis

PROJECT SUMMARY/ ABSTRACT
Individuals receiving maintenance hemodialysis (HD) have exceedingly high mortality, driven largely by
cardiovascular events. The rate of sudden cardiac death (SCD) in the HD population exceeds that of the
general population by more than 20-fold. Risk factors for SCD such as structural heart disease and conduction
abnormalities are common among people with end-stage kidney disease, but traditional preventive strategies,
such as antiarrhythmic medications and implantable cardioverter defibrillators, do not lower SCD risk in HD
patients. However, medication-provoked SCD may be preventable, and, to-date, has been understudied in HD
patients. Dialysis patients are often prescribed medications that have the undesirable, off-target effect of
delayed ventricular repolarization, which manifests as QT-interval prolongation on an electrocardiogram, and
can trigger fatal arrhythmias. Although more than 50% of dialysis patients are prescribed medications that can
prolong the QT-interval (e.g. certain antidepressants, antibiotics, antiemetics), there are critical knowledge
gaps about the cardiac safety of these medications. In fact, their safety profiles rest on data obtained from
healthy volunteers and have not been explicitly evaluated in HD patients. By executing the proposed studies,
we will provide a comprehensive understanding of the essential safety data relevant to the prescription of non-
cardiac QT-prolonging medications to HD patients. In Aim 1, we will determine the relative SCD risk of the
most commonly prescribed non-cardiac medications with higher QT-prolonging potential vs. clinically relevant
comparator medications with lower QT-prolonging potential among HD patients. In Aim 2, we will identify
modifiable clinical factors (e.g. dialysate composition and concurrent prescription medications) that may be
targeted to mitigate SCD risk from QT-prolonging medications. In Aim 3, we will identify prescribers of higher
risk QT-prolonging medications and associated encounters that should prompt medication reconciliation and
decision support tool use. Then, in Aim 4, we will develop individualized decision support tools for QT-
prolonging medication prescribing that integrate many comorbid conditions, HD treatment, and medication-
related risk factors. This work will yield decision support tools that facilitate personalized SCD risk
assessments and safer prescribing of QT-prolonging medications to reduce SCD risk among HD patients.
Moreover, the decision support tools generated in this project will serve as the subject of future pragmatic trials
testing the impact of tool implementation on cardiovascular outcomes.

Public health relevance
PROJECT NARRATIVE Hemodialysis patients experience a disproportionately high burden of sudden cardiac death. Medication- provoked sudden cardiac death (i.e. death triggered by QT-prolonging medications) may be preventable and has not been studied enough in this population. Our project aims to uncover medication-related risk factors for sudden cardiac death and develop clinical decision support tools that will promote safer medication prescribing.